PHYSIOLOGIC BASIS FOR INOTROPIC SUPPORT IN THE NEWBORN

To determine pharmacokinetic response of dopamine or dobutamine in term and preterm infants clinical evaluation hemodynamics and myocardial performance will be compared following various clinically acceptable rates of drug infusion.